Family Study of African Americans & Vuln. Factors Among

Family Study of African Americans This project was a five year study of black children ages 8-17 at high and low risk for alcohol-related problems based on a history of parental alcoholism. A prospective design was used to identify the specific disorders for which these children are at heightened vulnerability, and salient risk and protective processes in the development of the various types of childhood disorders. The major goals of the study were: 1. To examine the extent and patterns of psychopathology and behavioral problems among the offspring ages 8-17 of black alcoholic parents; 2. To assess the role of familial transmission of alcohol abuse/dependence and comorbid psychopathology, including substance abuse/dependence, in the pathogenesis of alcohol abuse in children; and 3. To identify multiple risk and protective indices of the pathogenesis of alcohol problems in black youth in order to yield information on the key targets of prevention and intervention. The key features of the study were: the sample of black alcohol abusers with young children about which there are sparse data; the epidemiologic source of the sample, which strengthened the generalizability of the findings and minimizes the bias in ascertainment of minorities from specialty treatment settings; the application of an epidemiologic family study paradigm, which permitted assessment of factors associated with familial transmission of risk factors and the mechanisms thereof; evaluation of the role of comorbidity of anxiety disorders and alcoholism in the transmission of alcohol-related problems; comprehensive assessment of vulnerability factors from broad domains or risk encompassing personal, family, and environmental attributes including community violence; the provision of knowledge essential for prevention through the assessment of protective factors which may inhibit pathogenic processes among children at high risk. Data collection of this study was completed at Yale University before the Principal Investigator’s relocation to the NIMH. The resources of our section have been devoted to preparation of these data for analysis and subsequent publications. This research provides a model for conducting studies of social epidemiology of mental disorders and substance abuse. During the past year, we have completed data cleaning and coding. The data are now ready for statistical analyses of the key study questions. We are continuing to analyze these data and are submitting manuscripts for publication. Substance abuse and its sequelae, particularly AIDS and interpersonal violence, constitute a contemporary public health crisis of ever-widening impact. The increasing risk of substance abuse in youth, particularly among urban minorities, reveals the need for prevention and early intervention measures. Elucidation of the role of specific familial and sociocultural factors in the development of drug use and abuse would yield targets for primary and secondary prevention of substance abuse and its complications. Vulnerability Factors Among Migrant Puerto Ricans This project proposes to integrate family and migrant study methodology in a five-year prospective epidemiologic study of adolescent offspring of native and migrant Puerto Rican substance abusers and controls. The wave of migration of Puerto Ricans to Connecticut over several decades provides an exceptional opportunity to differentiate cultural, familial, and individual risk and protective factors for adolescent drug use and abuse. Puerto Ricans are an important yet understudied ethnic subgroup characterized by an apparently low prevalence of substance use and abuse on the island of Puerto Rico, yet by a prevalence of AIDS that is among the greatest in the world. Migrant study methodology permits identification of environmental risk factors for substance use/abuse by comparing the disease experience of biologically similar subgroups in their native and adopted environments. The family study method enables the identification of transmissible components of a condition by comparing the rates and risk factors for diseases in relatives of cases with those of controls. Combining these two approaches in a single study to investigate risk factors for substance abuse allows us to: a) identify the relative contribution of family history of substance abuse and psychopathology on drug use and abuse in Puerto Rican adolescents while taking into account the influence of cultural environment, and b) identify the relative contribution of cultural factors on the risk of adolescent substance use and abuse, while taking into account background familial factors. The main aims of the study are: (1) To elucidate familial patterns of substance use and abuse and comorbid psychopathology between island and mainland Puerto Ricans; (2) To investigate the role of specific sociocultural factors in the development of adolescent substance use and abuse; (3) To identify and model the dynamics of the salient risk and protective factors at the individual, familial, and environmental levels for Puerto Rican adolescents at high and low risk for the development of substance abuse by virtue of parental substance abuse, and; (4) To conduct a longitudinal follow-up of the offspring to examine transitions in substance use status, and the association between the early patterns of substance use and comorbid psychopathology (including course and outcomes), as well as examine the stability of the assessments. Data collection of this study was completed at Yale University before the Principal Investigator’s relocation to the NIMH. The resources of our section have been devoted to developing analytic models for this complex data set comprised of families nested within sites. There are several manuscripts in preparation to report the results of this unique study. This project serves as a model for cross-cultural research that uses the migrant study design to identify specific cultural risk factors that may serve as targets for prevention and intervention. We have continued to analyze the data from this migration study of families in the U.S. and San Juan. We have published one paper this past year (Dierker et al, 2006), and have submitted a second paper (Merikangas et al, submitted), and have a third that should be submitted within the next few weeks (Herrell et al, in preparation). We are also developing a comparable family study here at the NIMH to study Hispanics in the Washington, D.C. area.